Leveraging genomic approaches to define sterol transport in Cryptococcus neoformans

ABSTRACT
Cryptococcus neoformans is a devastating opportunistic fungus that causes hundreds of thousands of deaths
each year, mainly in developing countries. The most abundant component of its plasma membrane is ergosterol,
which is also a compelling topic of study because it is the target of the most powerful antifungal drugs available.
How this compound is transported within the cell has never been studied in C. neoformans, constituting a major
gap in our knowledge of a critical lipid. Our preliminary results suggest that novel factors are involved in this
movement, and that identifying them may be amenable to genetic approaches.
The long-term goal of our research is to define the mechanisms of lipid transport in C. neoformans, to advance
our fundamental understanding and improve the outcome of this dangerous infection. In this R21 proposal we
focus on ergosterol transport. In Aim 1 we will apply a whole genome-scale genetic screen to discover genes
whose products influence ergosterol levels at the plasma membrane. In Aim 2 we will isolate and investigate
sequences that suppress a defect in retrograde traffic of ergosterol from the plasma membrane to the endoplas-
mic reticulum. In Aim 3 we will address the functions of prioritized genes from the first two aims, including studies
of growth, virulence, sterol content, and protein and lipid localization. These experiments will be enabled by our
expertise in cryptococcal biology and advice from expert colleagues, which we will integrate into thoughtful and
rigorous studies. Together, they will increase our understanding of cryptococcal ergosterol transport and position
us for further mechanistic investigations of proteins that we discover to be involved in this process.
Current antifungal drugs that target ergosterol and its synthesis are hampered by factors that include toxicity,
drug interactions, and resistance. It is therefore critical to find other vulnerabilities in this system that can be
productively exploited – our proposed studies are a focused step on this path. Completing them will advance
genomic methods for fungal discovery, deepen our knowledge of lipid transport, and open the door to future
mechanistic studies.

Public health relevance
PROJECT RELEVANCE / NARRATIVE This research is highly relevant to public health because the organism under study causes serious human illness for which current therapies are not adequate. Effective antifungal drugs target ergosterol (the yeast equivalent of cholesterol), but nothing is known about how Cryptococcus neoformans moves this lipid within the cell to regulate its levels at the surface. Filling this gap in knowledge may advance treatment of cryptococcal infection. This work will also contribute to basic science knowledge, which will provide insights into other pathogenic fungi and areas of biology.